CHARACTERIZATION OF OPTICAL FIBER PROBES FOR IN VIVO RAMAN SPECTROSCOPY

In Vivo Raman spectroscopy requires use of optical fiber probes for laser light delivery and collection of return Raman signals. Fluorescence and Raman background generated in the silica fibers hinder measurement of Raman spectra from biological tissue samples in vivo. We are developing and evaluating various optical fiber probes in which laser band pass filter and cut-off filters are incorporated. Dielectric band-pass filter incorporated in the excitation fiber eliminates background generated in the fiber and allow only the excitation light to illuminate the tissues. A dielectric cut-off filter incorporated in the collection fibers blocks the laser light from entering the fiber and passes only the Raman scattered light emitted by tissues. We are working closely with Visionex and currently evaluating the performance of their probes. Parameters such as the transmission wavelength, efficiency of the filters, the extent to which the fiber background is suppressed, and also the compatibility of these for clinical measurements are being evaluated.